Immunopathology Core

PROJECT SUMMARY
The specific aim of the Immunopathology Core Program (IPC) is to provide pathology
and immunology support to COBRE and other Oklahoma Center for Respiratory and
Infectious Diseases (OCRID) investigators. Services provided by the IPC include a broad
range of pathology support including gross necropsy and tissue collection, tissue
processing, sectioning of either frozen or paraffin-embedded tissues, routine and special
stains, immunohistochemistry (IHC), immunofluorescence (IFC), and coordination of
ancillary services (clinical pathology, bacteriology, virology, toxicology). Immune
responses important in the development of disease are characterized by evaluation of cell-
mediated immunity (ELISPOT, flow cytometry for intracellular IFNγ) and phenotypic
identification of inflammatory cells within lesions (IFC, IHC, flow cytometry). The IPC
will also coordinate with the Animal Models Core (AMC) and Molecular Biology Core
(MBC) to assist investigators with humoral immunity (serology, ELISA) and quantitation
of cytokine gene expression (real-time PCR) respectively. To achieve this aim, the IPC is
staffed by three board-certified pathologists with experience in animal models and
respiratory/infectious disease research and an experienced, extensively cross-trained
technician. The IPC has the resources in place to serve as the foundation and a strong
institutional commitment to ensure development of the IPC into a self-sustaining facility
integral to the research infrastructure of OCRID.